Development of Transgenic Mouse Model Resources for Red Fluorescence-Based Genetically Encoded Indicator Studies

Scientific Abstract
By expressing fluorescent reporters, such as green fluorescent protein (GFP) or red fluorescent protein (RFP)
downstream of specific promoters or fusing them with endogenous genes, a range of cellular processes can be
easily tracked and studied using fluorescence microscopy. Fluorescent reporters become even more powerful
when they are tagged with a protein domain that transforms their function into an indicator of specific cellular
processes, and they are typically referred to as ‘genetically encoded fluorescent indicators.’ Such indicators have
been specifically designed by researchers to detect changes in ion concentration, membrane potential, and pH
and have been used to generate transgenic mouse models for in vivo studies. The vast majority of these
transgenic mice expressing genetically encoded fluorescent indicators utilize GFP as the fluorescent moiety.
Unfortunately, major limitations of GFP-based indicators are phototoxicity and tissue autofluorescence which
make it difficult to differentiate signal from the noise. Although RFP-based indicators can overcome these issues
and they provide greater tissue penetration depth, there are not many animal-model resources currently available
in the red emission range. The goal of this proposal is to develop mouse models expressing RFP-based
indicators, characterize them, and make them available to the scientific community.
We will utilize a novel clustered regularly interspaced short palindromic repeats (CRISPR)-based genome
engineering approach called RE-CREATING (RE-engineering, with CRISPR, of
previously Engineered Alleles To Insert New Genes), to generate two conditional knock-in mouse models. A
popular and well-studied mouse strain that expresses a green genetically encoded fluorescent indicator will be
used as the parental strain. The transgene locus in this parental strain will be re-engineered by swapping the
GFP-based indicator for a RFP-based indicator, without disrupting any of the regulatory elements. The newly
developed RFP-based indicator mouse models will be suitable to study any cell type of interest simply by
crossing them with a Cre driver mouse of choice. Our models will enable imaging of dynamic intracellular
processes such as changes in calcium activity and membrane potential, which can be challenging and/or
inconsistent across tissues in currently available GFP-based models (due to phototoxicity and autofluorescence).
We will use vascular physiology techniques (e.g., pressure myography and sharp microelectrode measurements
of membrane potential) to characterize and validate the RFP-based indicator mouse models. Overall, this project
will provide a much-needed resource to the scientific community and opens the door for imaging of dual indicator
mice and/or allows for imaging of processes not traditionally possible with GFP-based mouse models.

Public health relevance
Narrative Scientists use fluorescent indicators as research tools to sense dynamic changes in the concentration of a molecule of interest within a cell. Even though green fluorescent proteins comprise the most commonly used indicators, autofluorescence in the green emission range of mammalian tissues poses challenges in studies using mice carrying genetically encoded fluorescent indicators. The aim of this proposal is to rapidly re-engineer an existing green fluorescent protein-based genetically encoded indicator mouse line to express red fluorescent protein-based indicators and make them available to the broader scientific community needing such tools.